Role of Merkel cell polyomavirus small T antigen in persistent infection

PROJECT SUMMARY/ABSTRACT
Merkel cell polyomavirus (MCV) is a common virus that establishes life-long persistent infection in human skin.
Yet, in elderly and immunocompromised patients, MCV can cause the aggressive skin cancer Merkel cell
carcinoma (MCC). MCV replicates as a circular episomal DNA in infected cells, however, viral DNA is clonally
integrated in MCC tumors, which allows stable expression of viral T antigens that drive malignant transformation.
Serological and genetic evidence show that MCV replication precedes viral integration and transformation,
indicating that inhibition of virus replication is a promising strategy to prevent MCV-associated MCC. How MCV
gene expression regulates virus replication is poorly defined but is believed to be controlled by two bidirectional
early and late promoters located in the non-coding control region. Critical MCV promoter elements and their
regulation by host transcription factors and epigenetic regulators remain unknown.
The MCV T antigen gene encodes two conserved replication proteins: large T (LT) and small T (ST). While LT
is a well-established replication helicase that directly binds to the viral replication origin, the functional role of ST
as a replication accessory factor is poorly understood. We generated a ST deletion MCV mutant (MCVΔsT) virus
and found that while MCVΔsT initiates viral DNA replication similar to wild-type MCV, it cannot complete genome
replication and encapsidation. Viral early and late mRNA expression is largely turned off in MCVΔST, which can
be rescued by trans expression of ST. Consistent with ST being a viral transcriptional regulator, an unbiased
proximity-based ST-host protein interaction study (together with confirmatory immunoprecipitation) identified
multiple transcriptional regulators Cux1, c-Jun, BRD9, and CBP histone acetyltransferase interacting with ST.
Of these regulators, CBP inhibition significantly attenuated ST-mediated viral early and late mRNA activation,
suggesting that CBP histone acetyltransferase mediates viral transcriptional control by ST.
Our preliminary results show that inhibition of CBP suppresses not only viral mRNA expression in replicating
MCV, but also viral T antigen mRNA expression in MCV-transformed MCC. We hypothesize that, together with
the MCV LT replicative enzyme, ST controls viral gene expression by altering the epigenetic state of viral
chromatin through interaction with CBP and transcription factors. The goals of this proposal are: (1) to define
MCV early and late promoter sequences, (2) to investigate the impact of ST on viral chromatinization and the
epigenetic state of the virus genome focusing on histone marks affected by CBP; and to identify transcription
factors that activate the viral promoters in the context of ST and CBP, and (3) to directly visualize single-molecule
binding of ST, LT, and CBP to the viral DNA through C-Trap laser capture confocal microscopy. Defining the
transcriptional functions of MCV ST on viral gene expression will lead to strategies to disrupt MCV replication for
the prevention and control of Merkel cell carcinogenesis.

Public health relevance
PROJECT NARRATIVE Merkel cell polyomavirus (MCV) is a common virus that chronically infects human skin cells, and cases of the aggressive skin cancer Merkel cell carcinoma (MCC) caused by MCV have been steadily rising in immunocompromised populations. Elevated MCV replication and subsequent integration of viral DNA into the cellular genome are important pathogenic steps in MCC development. This research will define the mechanism of viral gene expression regulated by the viral small T (ST) and cellular transcription regulator proteins, which is essential for MCV replication.